2014 Chemotactic Cytokines Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY Chemokines, the structurally homologous, functionally distinct family of chemotactic cytokines together with their cognate classical signaling and atypical non-signaling receptors comprise a complex molecular network involved in nearly all aspects of human health and disease. The 2014 Gordon Research Conference (GRC) on Chemotactic Cytokines: Positioning Cells in Immunity and Disease is a world premier meeting devoted entirely to understanding these important molecules. This will be our 11th Chemokine GRC, which has been held every other year since 1994, when chemokines first burst onto the scene as the largest cytokine gene family in the human genome. Similar to each preceding conference in this series, Chemokine GRC 2014 will bring together scientists from a broad range of biomedical disciplines to showcase the latest unpublished research findings that cover all aspects of chemokine function and provide a high-quality scientific forum to discuss their potential implications, including translation to the clinic. The program of this meeting will cover basic biochemical and biological aspects of chemokines as related to their contributions to leukocyte migration and emigration, immune tissue organization and function, and their role in inflammation, infection, autoimmunity and cancer. In addition, due to the success of the first Gordon Research Seminar (GRS) on Chemotactic Cytokines in 2012, we will be having this satellite meeting for bench scientists at the graduate and postdoctoral level again in 2014 titled Frontiers in Chemokine Research. GRS provides a forum where young researchers (e.g., students and post-doctoral fellows) can present their work and receive feedback on their ongoing research projects from their peers and a selected panel of senior experts. GRS will promote grassroots level integration and networking within the field of chemokine research. NIH funding is requested to provide partial support for registration for participants. We fully anticipate that the scientific discussions, research talks, poster sessions, and informal interactions between the participants of this conference will contribute to advancing our understanding of molecular mechanisms of chemokine involvement in disease pathogenesis. This will lay the ground work for the development of new collaborative projects, which will lead to new discoveries and ultimately new therapies and approaches to treat debilitating human disease, including inflammatory, infectious and autoimmune diseases and cancer.

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Chemotactic Cytokines and the satellite Gordon Research Seminar will bring together chemokine scientists from a variety of biomedical disciplines at all levels of this endeavor, including established investigators, junior investigators, and future generations of chemokine researchers. Scientific presentations, discussions and poster sessions during this conference will expand our understanding of the mechanisms by which chemokines contribute to health and disease. It is anticipated that the collegial and cooperative atmosphere that has traditionally characterized these conferences will provide the perfect setting for the intellectual development, cross-fertilization and future collaborations that are so vital to keep this field at the forefront of scientific innovation and discovery. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Chemokines were first identified as leukocyte chemoattractants. Subsequently, they have emerged as universal signals of intercellular communication affecting practically all cell types and playing important roles in many complex physiological and pathological processes. Chemokines participate in embryogenesis, immune organ development and function, host defense as well as contribute to cell communications in the brain. Importantly, chemokines and their cognate receptors also significantly contribute to many human diseases, including inflammatory, infectious and autoimmune diseases as well as tumor growth and metastasis. Therefore chemokine pathways have been traditionally considered attractive targets of pharmacological intervention. Anti-chemokine therapeutics have become part of current medical practice. However, specific chemokine involvement and underlying molecular and cellular mechanisms of chemokine action in a variety of human diseases remain obscure, hampering further translational developments. Because of the pleiotropic effects of chemokines on many cells in a variety of organs and tissues, the results of relevant clinical and experimental studies have been disseminated through hundreds of different specialist journals and at specialty conferences. Therefore, often the developments in one particular field of chemokine research fail to impact on the general scientific thinking on chemokines and do not influence the research in other disciplines or disease areas. The 2014 Chemokine Gordon Research Conference (GRC): Positioning Cells in Immunity and Disease, currently the word's only comprehensive chemokine meeting, attracts scientists from a variety of disciplines. Therefore we expect that scientific exchange will result in cross-fertilization among different disease areas and fields of chemokine research. New mechanistic aspects of chemokine research should also inspire and promote new approaches for therapeutic targeting chemokines and chemokine receptors. This meeting will also serve to integrate the chemokine research field geographically. Scientists from five continents are expected to attend this meeting, which should provide a basis for new collaborations spanning the globe. The meeting will take place in the US for the first time in ten years. Despite this we expect a significant European, Asian and Australian contingent to participate, with invited speakers coming from all over the world. The third level of integration will hope to achieve at this GRC is generational. The most prominent age group of participants at the last Chemokine GRC 2012 were the under 30 year olds and thus were either graduate students or post-doctoral fellows. To integrate, empower and educate this new generation of chemokine scientists, Chemokine GRC will be linked for the second time with a satellite symposium Gordon Research Seminars (GRS) Frontiers in Chemokine Research which is devoted entirely for young bench scientists. In addition, there are five invited speakers at the GRC at the level of Assistant and Associate Professor. To ensure that the GRC captures the most recent breakthroughs, 20 speaking slots for "short talk" have been reserved for late breaking talks selected from abstracts, and 12 speaking slots for "flash talks" have been reserved for talks selected from posters. These talks are most likely to be presented by young investigators. Thus, the scientific program of Chemokine GRC 2014 reflects the three aforementioned aspects of diversity within the field of chemokine research. We plan to bring together the most productive researchers in the field working in different biomedical disciplines and disease areas, coming from different countries and representing different age and experience groups. The central focus of this conference will be to advance our understanding of the mechanistic functions of chemokines and their role in human disease and our overall goal is to provide an ideal setting for successful Chemokine GRC and GRS 2014. Our specific aims are: 1. To bring together the most talented and innovative leading scientists in the field of chemokine research and encourage them to showcase in oral and poster presentations their latest unpublished results and new theoretical concepts. 2. Invite the most experienced, seasoned chemokine researchers as discussion leaders and together with them create a conference ethos that will foster free, open but also critical discussion. 3. To allow novel uncharted aspects of chemokine research to be presented, discussed and assessed. 4. To provide an inclusive conference environment encouraging interaction between scientists working in different disciplines of chemokine research leading to productive cross-fertilization and collaborations, including those between different generations of chemokine researchers. 5. To expose graduate students and post-doctoral fellows to new results and concepts in chemokine research and provide possibilities for their direct professional and social interactions with senior scientists in the field. 6. To provide a dedicated forum for young bench scientists allowing them to gain confidence, exchange ideas and experiences, interact in formal and informal settings and receive concerted mentoring. This application requests NIH support for partial coverage of travel and registration fees of speakers, and discussion leaders. Such support is critical to attracting the best possible attendees to this premier, longstanding conference.